WOMENS ANGIOGRAPHIC VITAMIN &ESTROGEN (WAVE) TRIAL

The purpose of WAVE is to determine if female hormone replacement therapy (HRT) or antioxidant vitamins (c and E) will limit the progression of coronary artery disease (CAD) in post-menopausal women. This NHLBI-multicenter trial has randomized post-menopausal women with angiographicall documented CAD to HRT, vitamins, both or neither. After approximately 3 years follow-up, the subjects will undergo repeat coronary arteriography. The baseline and follow-up arteriograms will be compared to assess if the therapies were beneficial.